Integrated Genomic and Functional Studies of Immunotherapy for Multi-Food Allergy

PROJECT SUMMARY
Food allergies (FAs) are a world-wide problem, and allergies to multiple foods are particularly problematic. In
the U.S., ingestion of offending food allergens is the most common cause of anaphylaxis seen in hospital
emergency departments (EDs), and it is estimated that ~30,000 food-induced anaphylactic events are seen in
U.S. EDs each year; sadly, ~200 of these events prove fatal. Peanuts or tree nuts cause the majority of these
deaths, and a recent survey in the U.S. found that 1.4% of the population is allergic to peanuts or tree nuts and
~30% of patients with FAs have allergies to multiple foods. In peanut allergy (PA), landmark studies by A.
Wesley Burks and colleagues have shown that children can be desensitized to peanut via an oral
immunotherapy (OIT) protocol. We have replicated these results in adults and children, and also have carried
out a pilot study showing that FA patients can be desensitized to multiple food allergens simultaneously (i.e.,
multi-OIT). Moreover, we found that there were fewer adverse events in the build-up phase of multi-OIT if
patients received the anti-IgE antibody, omalizumab, concomitantly with multi-OIT.
In an effort to improve understanding of the systemic and local (i.e., GI) immune responses that underlie PA
and therapeutic responses to OIT, we are currently conducting a placebo-controlled, randomized, phase 2
clinical trial of OIT in 120 children and adults with PA (the POISED trial), and are applying state-of-the-art
human immune monitoring methods to analyze blood and GI tissue specimens of participants in that study. In
this AADCRC U19 renewal application, we propose to conduct a pilot, placebo-controlled, randomized, phase
2 clinical trial of OIT with or without omalizumab or the anti-IL-4Rα antibody, dupilumab, in children and adults
with multiple FAs (multi-FAs). We propose to measure a broad range of blood and GI biopsy cellular findings,
as well as serologic and clinical findings, in longitudinal samples from multi-FA participants undergoing the trial,
as well as from appropriate control participants (i.e., multi-FA participants who are not treated, healthy controls,
and atopic controls without FA). We will use these data to define how key systemic or GI tissue immune
parameters change during multi-OIT, and which are most predictive of the nature and durability of patient
responses to this therapy. Specifically, we will evaluate whether there are blood- or GI tissue-derived
biomarkers that predict therapeutic responses to individual allergens, or to all allergens, in multi-OIT. In
addition, we will seek to identify immune monitoring parameters, including findings derived from analyses of
basophil phenotype and function that can be rapidly performed in a clinical laboratory using small amounts of
blood, that could be used to predict the clinical reactivity to offending allergens in multi-FA subjects, to improve
the safety and efficacy of OIT protocols, and/or to tailor the OIT protocol to each individual subject.

Public health relevance
PROJECT NARRATIVE Food allergy (FA) to multiple foods is increasingly common and can cause serious illness and death in children and adults. We will use innovative approaches for immune monitoring and data analysis of blood and GI tissues to investigate factors responsible for FA, and to improve our ability to manipulate the immune system to safely treat people with FAs. We will also try to develop rapid blood tests that can be used to tailor treatment for each individual patient with FA to improve treatment safety and efficacy.